Cortical circuits and neurotransmitters for taste aversion learning

Summary
Taste perception is a complex process that includes the chemosensory detection of a stimulus and information
regarding its valence - whether a stimulus is pleasant or aversive. The gustatory cortex is a central component
of the taste system and is involved in taste learning as well as decisions to ingest or reject a food. Thus, it is a
central component of the neural circuit involved in the assignment of a valence to a taste stimulus. To date, much
of the work on understanding how taste valence is encoded focused on the analysis of limbic inputs to the
gustatory cortex. This work has substantially advanced our understanding of the network taste perception and
learning but has not resolved the circuit mechanisms regulating taste valence. In this proposal, we take
advantage of a well-established form of taste aversion learning to modulate taste hedonic value and analyze the
contribution of neuronal and circuits mechanisms for the coding of valence. The multi-level approach we have
designed will bring together analysis of neuromodulatory signals on specific groups of cortical neurons and on
cortical circuits with in vivo imaging in awake mice to determine how valence is encoded. We will also use
selective manipulations of the expression of specific receptors and analysis of behavior to bring into focus the
role of specific neuronal signals in the formation and expression of taste valence memories.
The implications of the proposed work for public health are substantial. Changes in taste valence may emerge
as a side effect of cancer treatment or be associated with gastrointestinal disorders, preventing patients from
enjoying food and ingesting the calories they need to support their recovery. Furthermore, many neurological
and psychiatric disorders are associated with altered sensory perception, or with anhedonia, the loss of pleasure
associated with sensory experiences. The circuits for taste perception in human and rodents are quite conserved
and both species rely on valence to make decisions about food choices, providing a unique opportunity for
investigating common mechanism of sensory processing, as well as for the study of the circuit underpinning for
the association of sensory stimuli with their hedonic value. The focus of the proposed work on specific signaling
mechanisms and neuron types has the added potential of helping to identify novel targets for therapeutic
intervention.

Public health relevance
Narrative The study we propose here is designed to investigate the circuit mechanisms underlying the valence of taste stimuli. Taste stimuli have an intrinsic hedonic value: they can be pleasant or unpleasant. Taste valence can be modified by the association of a pleasant stimulus with a gastric malaise, like in the case of food poisoning. This form of learning induces aversion to the taste that triggered it and is through to depend on plastic changes in the gustatory insular cortex. Despite many years of study, the circuits and neurotransmitters involved in this form of learning are not well-understood. Here we propose to investigate the contribution of gustatory cortical circuits to the formation and expression of taste aversive memories. Results from the proposed work have important implications for public health. Cancer treatment can induce food aversion in patients, impairing their ability to consume the nutrients they need to recover. In addition, patients with psychiatric and neurological disorders display alterations in sensory perception, and/or impaired ability to process the affective dimensions of a sensory stimulus (anhedonia). Furthering our understanding of the circuit mechanisms regulating changes in the valence of sensory stimuli is a crucial step toward the development of novel therapeutic approaches.